RFA-DP-24-062, Physical Activity Policy Research and Evaluation Network

This application in response to Special Interest Project (SIP)-24-007 seeks to re-establish the Physical Activity
Policy Research and Evaluation Network (PAPREN) at the Prevention Research Center at UMass Chan in
collaboration with the University of Illinois Chicago and West Virginia University. We will further position PAPREN
as the leading national research network committed to advancing implementation research designed to increase
physical activity (PA) through community design interventions using cross sector and community engaged
approaches. Community design interventions are recommended by the Guide to Community Preventive Services
(Community Guide), included in Healthy People 2030, and form the basis of the Physical Activity Priority Strategy
of the CDC’s Division of Nutrition, Physical Activity and Obesity. Such interventions improve pedestrian and
bicycle transportation and land use systems and often require policies (e.g., Complete Streets) and plans (e.g.,
Master Plans) that facilitate them. Despite evidence supporting their effectiveness, research gaps regarding
effective strategies to support implementation of community design interventions remain. PAPREN will address
these gaps. In Aim 1, we will develop, test and disseminate an equity-focused implementation strategy designed
to foster cross-sector collaborations and community engagement that supports the implementation of the
Community Guide’s community design recommendation. The project will include a implementation strategy that
is a web-based, asynchronous training that focuses on the co-benefits (e.g., social connectedness, safety) and
unintended consequences (e.g., displacement) of community design interventions that promote PA and prepares
communities to engage in cross-sector collaborations tailored to community context. This project will be
developed and usability tested in collaboration with long-standing local partners in Worcester, MA with residents
who are low-income and/or racially and ethnically diverse. It will then be tested in a national sequential
explanatory mixed methods implementation study. In Aim 2, we will grow and support a vibrant, multi-disciplinary
and cross-sectoral Network. We propose three areas of Network activities: (1) A strategic approach to enhance
and expand the robust existing PAPREN multi-sectoral Network of researchers and practitioners; (2) Network-
wide activities that provide opportunities for members to enhance their knowledge and skills and identify
collaborative research opportunities; and (3) Two PAPREN Work Groups (Urban Community Design and Rural
Community Design), each with 3 subgroups (transportation, land use planning, and parks and green space) that
provide opportunities for researchers and practitioners to conduct collaborative implementation research. We
will deploy a multi-component Dissemination and Translation Plan designed to ensure that PAPREN’s activities
support the Network and that its research advances science and informs practice. We will also deploy a
systematic Evaluation Plan guided by a PAPREN-specific adaptation of the CDC’s Evaluation and Scientific
Impact Frameworks to monitor and improve the Network and identify successes and impact.

Public health relevance
This proposal will support the Physical Activity Policy Research and Evaluation Network (PAPREN) Coordinating Center at the Prevention Research Center at UMass Chan Medical School, in collaboration with the University of Illinois Chicago and West Virginia University. We seek to establish PAPREN as the leading national research network committed to advancing implementation research designed to increase physical activity using community design interventions through multi-sectoral and community engaged collaborations. We will accomplish this through two major aims: (1) We will conduct an implementation research study to develop an educational strategy that fosters cross-sector collaboration and community engagement that supports that implementation of physical activity supportive community design; and (2) We will grow and support a vibrant, multi-disciplinary and cross-sectoral Network that engages in community design implementation research to support physical activity.